ETEC Vaccine Development and Evaluation

Enterotoxigenic E. coli (ETEC) is the leading cause of diarrhea among travels to and children living in the endemic areas. This IAA will support the preparations of several ETEC colonization factor antigens, which will be deposited into the BEI repository.